TDP-43 Proteinopathy in ALS-FTD: Mechanism, Target Validation and Biomarker

Amyotrophic Lateral Sclerosis (ALS), a fatal adult onset motor neuron disease characterized by selective
loss of upper and lower motor neurons, and Fronto-Temporal Dementia (FTD), a common form of dementia
characterized by a progressive deterioration in behaviour, personality and/or language, share a common disease
spectrum. The neuropathology involving Transactivation response element DNA-binding protein 43 (TDP-43)
occurs in nearly all cases of ALS and large proportion of FTD, neurodegenerative diseases currently without
effective therapy. The overarching goals of this proposal are to clarify disease mechanism, determine a
therapeutic window for a novel AAV9 gene therapy, and develop a prognostic test for ALS. By developing
monoclonal antibodies designed to recognize cryptic exon encode peptides, we show that loss of TDP-43
splicing repression occurs in pre-symptomatic C9ORF72 patients. This novel finding would support the idea that
loss of TDP-43 function occurs during early stage of disease. In this application, we will establish this important
mechanistic insight. We hypothesize that it would be possible to develop a prognostic test for prodromal phase
of ALS, a critical unmet need in the field relevant for recruitment of patients at their earliest stage of disease and
for monitoring target engagement in clinical trials. Finally, emerging evidence support the idea that loss of TDP-
43 splicing repression impact on many critical pathways. In contrast to targeting each of these pathways for ALS,
we hypothesize that by targeting the mechanism of TDP-43 splicing repression, it may be possible to provide
benefit to patients if such therapeutic strategy can be delivered during early disease which can be determined
using this new diagnostic assay of TDP-43 “cryptic” peptide. As we showed previously that our AAV9-CTR has
the potential to complement the loss of TDP-43 function in ALS, we hypothesize that a window of opportunity for
this gene therapy can be defined in our mouse model lacking TDP-43 in spinal motor neurons. Together, results
from our proposed studies will have important implications for understanding disease mechanism, validating
therapeutic strategy and developing a prognostic test for the prodromal phase of ALS.

Public health relevance
The discovery of loss of TDP-43 splicing repression occurring in Amyotrophic Lateral Sclerosis (ALS) and Fronto-temporal Dementia (FTD) provided the opportunity to test whether such function is compromised during early stage of disease, develop prognostic test, and to design therapies to treat this illness, currently without effective treatment. We recently discovered that loss of TDP-43 function occurs in pre-symptomatic ALS-FTD patients, providing rationale to develop a prognostic test for sporadic ALS as well as for developing a therapeutic strategy to complement loss of this TDP-43 function for ALS.